A quantitative examination of cellular mechanisms that modulate the impacts of genetic variation - Renewal - 1

PROJECT SUMMARY
Predicting the phenotypic impacts of a mutation is a major goal in biology and medicine. But the paths linking
genotype to phenotype are difficult to navigate. For one, some phenotypes impact others, so the impacts of
mutation can stretch out across networks of related traits. One of my lab’s goals is to investigate the
relationships between basic features of cells (e.g., misfolded protein abundance, levels of protein-folding
chaperones, and cell growth rate) so we can predict some phenotypes from others. But doing so is not enough.
Predicting phenotype is more challenging than this because the impacts of mutation, and the networks of
related traits through which they spread, can change across contexts. By re-measuring the relationships
between traits in many different genetic backgrounds and environments, my lab endeavors to make headway
on one of the major goals of modern biology: predicting the phenotypic impacts of mutation in diverse contexts.
To achieve this goal, my lab conducts high-throughput experiments in the model eukaryote, budding yeast, that
simultaneously quantify the phenotypic impacts of many mutations across many environments. We interpret
these big datasets using diverse mathematical models and machine learning approaches. In some projects, we
quantify the correlations between phenotypes to infer the network through which a mutation’s influence travels
and how that network changes across contexts. For example, I recently measured the correlations between
yeast single-cell morphological traits, how they change across the cell cycle, and how this predicts which traits
are jointly influenced by mutation. In the next five years, my lab plans to apply a similar strategy to study how
the impacts of mutation travel through a regulatory network. In other projects, we deconvolute high-
dimensional data into an abstract genotype-phenotype map that uses shared mutant behavior across
contexts to improve fitness predictions. In the next five years, we plan to apply this approach to make better
predictions about how the fitness of drug-resistant yeast mutants changes across subtly different
concentrations and combinations of drugs.
Some of our work involves engineering libraries of mutant yeast strains to investigate scaling relationships
describing how molecular-level phenotypes (e.g., the levels of misfolded proteins or ribosomes) impact higher-
level properties (e.g., cell growth and fitness). Other work focuses on large collections of adaptive mutations
generated by laboratory evolution experiments. Our overall goal is to build predictive maps from genotype to
phenotype and, in so doing, to learn about molecular biology, and also generate tools to measure and predict
some phenotypes from others that will be broadly useful to the community.

Public health relevance
PROJECT NARRATIVE How a specific DNA sequence, or genotype, translates to an observable phenotype can change across environments, genetic backgrounds, or even cell types, obscuring our ability to make predictions about hereditary and infectious diseases from genetic data. This proposal uses novel, high-throughput technologies accessible in the model eukaryotic cell, Saccharomyces cerevisiae, to measure how phenotypes, and the phenotypic effects of mutations, change with context. Our goal is to combine high-dimensional data with mathematical modeling to learn when and how the impacts of mutation will vary across contexts, thus improving our ability to predict phenotype from genotype.